HHSN261201500003I; HHSN26100070; 400.020.0070.0001; NCI-DCEG; Appropriated; Automated evaluation of biomarker-stained slides; 09/24/2018-09/23/2023

HHSN261201500003I; HHSN26100070; 400.020.0070.0001; NCI-DCEG; Appropriated; Automated evaluation of biomarker-stained slides; 09/24/2018-09/23/2023